Spinal dopamine receptor mechanisms regulating the micturition reflex after spinal cord injury

Project Summary
We previously discovered a subpopulation of dopaminergic neurons that reside in the rat spinal cord. Following
spinal cord injuries (SCI), these neurons undergo plasticity and release a low level of dopamine (DA) to
modulate lower urinary tract (LUT) activity. However, we found the effects of DA on the recovered micturition
reflex cannot simply be interpreted by activation of either the D1 or D2 receptor alone nor by simultaneous
stimulation of the two. Instead, stimulating D1 receptors appears to synergize the effect induced by D2
activation on voiding in SCI rats. Recently, a D1-D2 receptor heterooligomer (heteromer) was uncovered in the
brain which is linked to several neurological behaviors or disorders. In the preliminary data, we detected D1-D2
heteromer levels in the rat lower spinal cord, and the expression of this receptor complex is upregulated
following SCI. Accordingly, we hypothesize that spinal D1-D2 heteromers regulate the micturition reflex in rats
with SCI and stimulation of this receptor complex improves involuntary micturition function. Using multiple
experimental approaches, including co-immunoprecipitation, ELISA, in situ proximity ligation assay, RNAscope,
quantitative PCR, western blot, micturition reflex and functional recordings, we will 1) determine whether spinal
D1-D2 receptor heteromers tonically regulate micturition reflexes in rats with SCI, 2) test whether co-
stimulating spinal D1 and D2 receptors increases heteromer formation and improves involuntary micturition
function in rats with SCI as a potential strategy for translation, and 3) elucidate whether the D1-D2 complex
acts on micturition function via an intracellular Gq/11-PLC-Ca++ signaling pathway. This project will challenge
traditional concepts concerning DA receptors in the spinal cord, aid in further appreciation of DA-ergic
machinery regulating the micturition reflex, and establish plausible pharmacotherapeutic targets for SCI-
induced urinary disorders.

Public health relevance
Narrative Lower urinary tract (LUT) dysfunction occurs after spinal cord injuries (SCI) although involuntary spinal bladder and urethral reflexes are established over time to facilitate partial recovery of micturition. We will investigate if dopamine D1-D2 receptor heteromers expressing in the spinal cord undergo plasticity after SCI and regulate the micturition reflex, and test if stimulating the receptor complex improves involuntary micturition function. This project will challenge traditional concepts of dopamine receptors in the spinal cord, help further to understand dopaminergic machinery regulating micturition reflexes, and establish potential pharmaco-therapeutic targets for SCI-induced urinary disorders.